A PHASE 1 STUDY OF IDURD AS A RADIOSENSITIZER IN LOCALLY ADVANCED CERVIX CANCER

This protocol has recently opened. The first two patients are just beginning treatment. A flyer is being sent out to improve accrual.